South American Program in HIV Prevention Research (SAPHIR)

Project Summary/Abstract
Effective HIV prevention interventions require the integrated analysis of behavioral, biological, and social
transmission patterns within specific cultural contexts. The South American Program in HIV Prevention
Research (SAPHIR) program offers developing investigators from the U.S. an intensive, structured program of
education and practical research training on comprehensive HIV prevention in an international environment.
Specific Aim 1. To provide researchers from the U.S. with a structured program of education and
training based on a focused research topic within the field of HIV prevention in Latin America. SAPHIR
program trainees are paired with research mentors from the U.S. and Latin America to develop an independent
research program incorporating both secondary analysis of existing data and design of an original research
study protocol. Potential research topics include behavioral, epidemiological, clinical and laboratory issues
related to HIV prevention within specific Latin American contexts.
Specific Aim 2. To provide a program of didactic instruction and interactive seminars addressing
integrated approaches to HIV prevention in international settings. The training program includes a
weekly series of lectures and seminars on key areas of global HIV prevention, including lectures, journal clubs,
research presentations, and ethics case conferences. The conceptual framework for the educational program
is based on the intersection of scientific disciplines through the lens of comprehensive HIV prevention.
Specific Aim 3. To build the capacity of a collaborative network of international investigators and
research centers with individual areas of scientific expertise to produce integrated approaches to HIV
prevention research in Latin America. In addition to practical training for young investigators, a secondary
aim of the program is to promote inter-institutional collaboration and capacity-building for participating research
centers. Graduates of the program accomplish the following goals: 1) Acquire a foundation of knowledge in the
four core areas of comprehensive HIV prevention (epidemiology, diagnosis, treatment, and prevention); 2)
Complete a secondary data analysis and prepare a corresponding abstract for submission to an international
scientific conference; 3) Design an independent research sub-study; 4) Prepare a study protocol that meets
requirements for the ethical conduct of research with human subjects as defined by the UCLA Office for
Human Research Participant Protection; 5) Submit a funding proposal for peer review and receive a written
summary statement; and 6) Present results of their research in a local community venue and at an annual
conference of program trainees and mentors. All SAPHIR graduates acquire the exposure, skills, and practical
experience necessary to gain admission to competitive post-doctoral training programs and to build an
academic career in international HIV prevention research.

Public health relevance
Project Narrative Relevance to Public Health: The newest generation of physician scholars recognizes the need for global approaches to HIV prevention but lacks structured opportunities for research training in international sites. Our dedicated program of education and practical training in international HIV prevention studies fills an important deficit in current AIDS research.